Role of nucleosome dynamics in epigenetic inheritance

PROJECT SUMMARY
Chromatin states encode epigenetic information and must be stably transmitted to daughter cells to maintain
gene expression and cell identity. How the information contained within the chromatin structure and histone
modifications is transmitted to daughter cells during cell division remains largely unknown. My long-term goal is
to understand the mechanisms of epigenetic inheritance, with particular focus on nucleosome dynamics. In this
proposal, I will investigate how histone (H3-H4)2 tetramers, a critical component of nucleosomes (the basic unit
of chromatin) are transferred from parental to newly-synthesized DNA and assembled into nucleosomes during
the S phase of the cell cycle. Previous studies have shed light on nucleosome assembly of new (H3-H4)2
tetramers. However, the process whereby parental (H3-H4)2 tetramers are assembled into nucleosomes on
replicating DNA strands has not received sufficient attention due to the lack of suitable methods. Recently, we
have developed eSPAN (enrichment and sequencing of protein-associated nascent DNA), a novel technology
that enables, for the first time, the analysis of protein binding to the leading and lagging strands of replicating
DNA. Using this method, we have observed that the parental histone (H3-H4)2 tetramers prefer lagging
strands, supporting a non-random segregation model. Importantly, we have also found that the DNA
polymerase ε and DNA helicase may play a role in the parental histone (H3-H4)2 tetramer transfer process.
Based on these significant preliminary results, I hypothesize that parental (H3-H4)2 tetramers are assembled
into nucleosomes by histone chaperones, chromatin remodeling complexes and DNA replication machinery.
To test this hypothesis, I will identify the proteins involved in parental histone (H3-H4)2 segregation during DNA
replication (Aim 1); and investigate the molecular mechanism whereby polymerase ε and the DNA helicase
contribute to parental nucleosome assembly (Aim 2). The proposed studies will elucidate the mechanisms of
the parental (H3-H4)2 tetramer transfer process. Mutations in, or aberrant regulation of, proteins involved in
chromatin replication, such as histone chaperones, histone modification enzymes, and chromatin remodeling
complexes, have been directly linked to breast, gastrointestinal, and prostate cancers. Thus, the parental
histone transfer and assembly mechanisms I aim to discover and characterize in this study will not only provide
novel insights into the fundamental process of epigenetic inheritance but also create new opportunities for
human cancer therapy.

Public health relevance
PROJECT NARRATIVE How epigenetic states are inherited during cell division remains largely unknown. This proposal aims to elucidate the molecular mechanism whereby parental histone proteins are assembled into nucleosomes following DNA replication, a process that has not received sufficient attention for the lack of suitable methodologies. Taking advantage of eSPAN, a novel technology we recently developed for the association analysis of proteins with the leading and lagging strands of DNA replication forks, I will explore the hypothesis that parental histone (H3-H4)2 tetramers are assembled into nucleosomes by proteins central to chromatin replication.